In Vivo Functional Analysis of Chromosome 7q22 Deletions in Myeloid Malignancies

ABSTRACT Recurring losses of large chromosomal regions are a hallmark of pediatric and adult cancer genomes that pose exceptional challenges for uncovering how these deletions contribute to malignant growth. Monosomy 7 (-7) and del(7q) (-7/del(7q)) are recurring cytogenetic abnormalities in de novo myeloid malignancies that are strongly associated with cases of myelodysplastic syndrome (MDS) and acute myeloid leukemia (AML) arising in children and in adolescent/young adult (AYA) patients with inherited cancer predispositions and in those who develop myeloid malignancies after treatment for a primary cancer. Therapy-induced MDS and AML (t-MDS and t-AML) are particularly relevant to the pediatric and AYA population due to modern intensive treatment protocols for many solid cancers, which are frequently curative. As a result, there is a large and growing population of “at risk” pediatric and AYA cancer survivors. Unfortunately, t-MDS/t-AML and other myeloid malignancies with chromosome 7 deletions are highly refractory to current therapies. Extensive cytogenetic and genome wide analysis studies implicate deletions of chromosome band 7q22 in leukemogenesis; however, sequencing studies and transcriptome analysis did not reveal frequent homozygous inactivation of any candidate 7q tumor suppressor gene in myeloid malignancies. These data implicate haploinsufficiency for one or more 7q genes in leukemogenesis, which pose formidable challenges for elucidating the underlying molecular mechanisms. To address this fundamental problem, we deployed chromosome engineering to create 5A3+/del and 5G2+/del mice, which respectively harbor deletions in mouse chromosome bands 5A3 and 5G2. These deletions span ~4 MB of genomic DNA that is syntenic to the most common 7q22 deletions identified in human patients. 5A3+/del hematopoietic stem and progenitor cells (HSPC) exhibit “preleukemic” abnormalities, but these mice do not spontaneously develop MDS or AML. Preliminary studies of 5G2+/del mice also revealed HSPC abnormalities and exposing this strain to N-ethyl-N-nitrosourea (ENU) accelerated the development of hematologic cancer. We will utilize these novel models of 7q22 deletions to pursue the following specific aims: (1) to functionally interrogate hematopoiesis in 5G2+/del and 5A3+/del/5G2+/del mice and to observe cohorts of mice for the development of myeloid malignancies; (2) to investigate the effects of DNA damaging agents on 5A3+/del/5G2+/del HSPC; and, (3) to model the complex genetics of myeloid malignancies with -7/del(7q) by introducing cooperating mutations into 5A3+/del/5G2+/del HSPC and assessing the phenotypic and functional consequences in vivo. Genetically engineered mice that accurately model recurrent chromosome band 7q22 deletions found in human myeloid malignancies are a versatile system for performing functional studies and testing new therapeutic strategies.

Public health relevance
PROJECT NARRATIVE Deletions of chromosome 7 (monosomy 7) and loss of part of the long arm of this chromosome, which is called del(7q), are frequent cytogenetic aberrations in aggressive myeloid malignancies that are particularly common in inherited cancer predispositions and in cancer survivors. Chromosome band 7q22 is thought to harbor one or more genes that, when lost, contribute to the development of these cancers and to drug resistance. In this project, we will investigate novel strains of mice that closely model the 7q22 deletions found in human patients to understand how these deletions alter the growth of hematopoietic stem and progenitor cells, modulate response to genotoxins and cooperate with other mutations to cause leukemia.